Innate-adaptive immune bridging in gravidity-dependent immunity against placental malaria: a multi-omics approach

PROJECT SUMMARY/ABSTRACT
Malaria in pregnancy is one of the leading causes of infant death globally. Placental malaria (PM) is the main
mechanism by which malaria in pregnancy causes birth complications, such as preterm birth, stillbirth, and low
birth weight. During PM, Plasmodium falciparum (Pf)-infected red blood cells sequester to syncytiotrophoblasts
(STB) within the placental intervillous space, stimulating maternal immune cell recruitment and leading to other
placental pathologic changes. With increasing gravidity, the severity of PM decreases and birth outcomes
improve as pregnant women acquire Pf-specific antibodies (Abs) against a variant surface protein – VAR2CSA
- after repeated Pf exposures. Previous work shows that neutralizing Abs against VAR2CSA are important for
protection but do not entirely prevent neonatal complications, which suggests a key role for Ab-mediated effector
functions. Work by our group and others demonstrate that Ab-mediated effector functions are crucial for naturally
acquired immunity to malaria in children. We hypothesize that the myeloid compartment, phagocyte localization
at the materno-fetal milieu, and Ab repertoire adapt with repeated Pf exposure in a gravidity-dependent manner,
and that antibody-dependent phagocytosis is necessary for limiting PM pathogenesis and improving neonatal
outcomes. To test this hypothesis, we will leverage an extraordinary biobank of peripheral and placental blood,
plasma, and placental tissue collected from pregnant women enrolled in the DPSP clinical trial (U01 AI1431308).
In Aim 1, we will determine how malaria and gravidity impact the circulating and placental blood myeloid
compartment in pregnancy using single cell proteomic (CyTOF) and transcriptomic (scRNAseq) approaches. We
will test whether Pf infections and increasing gravidity result in an enrichment of circulating, FcγR-expressing
phagocytes. In Aim 2, we will determine how Pf parasitemia and gravidity shape myeloid cell - STB spatial
relationships in placental tissue using novel spatial proteomic (MIBI-TOF) and transcriptomic (NanoString DSP)
imaging approaches. We will test whether, with increasing gravidity, inflammatory maternal myeloid cell
infiltration will decrease and maternal phagocytes will preferentially localize to the STB. Finally, in Aim 3, we will
utilize in vitro models to determine how gravidity-induced Ab modifications influence Fc-mediated protection from
malaria in pregnancy. Together, successful completion of these studies will inform vaccine development and
therapeutic strategies to reduce the global burden of malaria in pregnancy.

Public health relevance
PROJECT NARRATIVE Malaria in pregnancy continues to result in significant maternal morbidity and mortality in sub–Saharan Africa, and placental malaria can result in adverse birth outcomes such as preterm birth, stillbirth, and low birth weight. With increasing gravidity, the severity of placental malaria decreases, and birth outcomes improve; but mechanisms driving this gravidity-dependent protection remain unclear. In this proposal, we will evaluate correlates and mechanisms of gravidity-dependent immunity to placental malaria and specifically determine the role of innate-adaptive immune bridging in this protection using a multi-omics approach.